Core A: Administrative Core

Summary The Administrative Core will provide a coherent organizational structure for the project. It will coordinate the following activities: (a) Financial management, (b) Administrative communication among institutions and between the project and NIH, (c) Scientific communication among investigators, (d) Preparation of annual Progress Reports, (e) Decision making by the P01 leadership team, (f) Annual meeting of investigators with the External Scientific Advisory Board, (g) Management of IP issues, (h) Monitoring regulatory compliance. The Program Administrator has extensive experience in these areas, including working with the P.I of this Program Project to manage its activities during the previous cycle, and coordinates closely with grants management officers at Boston Children's Hospital and all the other institutions involved.